Core B: Developmental Core

Core B: Developmental (Dev) Core Project Summary/Abstract
The mission of the Developmental (Dev) Core of the SD CFAR is to promote innovative directions in HIV
research by supporting local researchers, particularly early stage investigators and those from communities
which are underrepresented in research. The Dev Core is continually evolving new programs to meet the needs
of our members and to enhance our return on investment.
The specific aims of the Dev Core are:
1. Support and cultivate emerging investigators through pilot grants.
2. Train our new investigators by providing a range of educational and mentoring opportunities.
3. Recruit and retain the next generation of HIV investigators.
4. Respond rapidly to new research opportunities.
The Dev Core provides opportunities for early stage investigators, investigators new to HIV research and newly
recruited HIV research faculty to generate preliminary data for larger grant applications through pilot grant
awards. Applications are evaluated by the Developmental Grant Review Committee which represents a broad
range of HIV research expertise and all SD CFAR member institutions. Informed by regular reviews, member
surveys and our strategic planning process, the Dev Core has launched several new responsive grant
opportunities for community-driven research projects, post-doctoral fellows, and previous Dev grant recipients
in need of targeted small grant funding. The Dev Core also provides regulatory assistance through collaboration
with the Clinical Investigation (CI) Core.
The Dev Core cultivates the next generation of HIV researchers through training workshops, seminars and
formal mentorship opportunities. These programs facilitate the academic success of emerging researchers and
prepare them for leadership roles. Finally, the Dev Core operates a Rapid Review Board for the efficient
solicitation and review of applications for funding opportunities with quick turnaround times, such as certain
foundation grants and Administrative Supplements. The Dev Core continues its mission to support our
investigators and efficiently respond to new funding challenges and opportunities to more effectively nurture the
next generation of talented and independent HIV investigators.